Tracking transcriptome diversity in real-time

SUMMARY
Recent studies have provided unprecedented insights into how individual molecular mechanisms
are correlated to changes in gene expression levels. It is now recognized that substantial
transcriptome complexity arises from decisions involved in the processing of nascent mRNAs.
However, by and large, the many studies of gene expression have focused on characterizing
steady-state mRNA levels, even though living systems are inherently dynamic. Thus, a key open
question in functional genomics is: how to the dynamics of individual molecular mechanisms
combine to influence the cellular transcriptome? Our overarching hypothesis is that the fate of an
mRNA is governed by kinetic interactions underlying molecular efficiency across disparate steps
in the mRNA lifecycle – at the core, transcription elongation, mRNA splicing, and 3’ end cleavage.
Current knowledge of spatiotemporal coordination across these processes likely represents the
tip of the iceberg. Our work combines genetic, molecular, and cellular genomic techniques with
high-dimensional computational analyses to address fundamental themes in mechanistic
efficiency. First, we aim to dissect the kinetic basis for efficient mRNA biogenesis and maturation.
Work from our research and others has suggested that there is substantial variability in kinetic
actions and rate-limiting steps for mature mRNA production across genes. Determining the
molecular logic underlying this variability will inform our understanding of the molecular basis for
transcriptome complexity in both homeostatic and diseased cells. Second, we will investigate how
coordinated RNA processing decisions underlie mRNA isoform expression. Despite decades of
research on individual mechanistic steps, we are still unable to predict the expression of specific
mRNA isoforms in either homeostatic or dynamic cellular conditions. Building on our recent work,
we will characterize how coupled kinetic and spatial mechanisms regulate alternative mRNA
isoforms. Finally, we will determine how RNA processing kinetics underlie the regulation of cellular
transitions. The kinetics of gene regulatory processes likely play a crucial role in cellular
responses or transitions, by altering the order of molecular events or speed of processes to rapidly
regulate gene expression dynamics. Our research will result in insights crucial to uncovering the
cascade of molecular events that cumulatively establish steady-state gene expression levels, with
implications for improved therapeutic designs or strategies that target the early progression of
cellular shifts rather than only the final outcome.

Public health relevance
NARRATIVE Phenotypic complexity across cells, tissues, and disease states is driven by coordinated changes in gene regulation that allow a continuum of gene expression levels to arise from the same genome sequence. Though profiles of steady-state gene expression levels are central to our understanding of the molecular underpinnings of developmental processes, immune response, cancer, or the efficiency of drug targeting, they do not fully capture the dynamic nature of cellular processes. This proposal focuses on understanding the kinetic interplay between steps of RNA biogenesis and maturation, in particular, the speed and precision of mechanisms responsible for establishing mRNA levels in cells.